Rapid Acute Leukemia Genomic Profiling with CRISPR enrichment and Real-time long-read sequencing

PROJECT SUMMARY
The parent award (1R21CA280520-01) aims to develop fast and cost-effective methods of detecting Acute
Myeloid Leukemia (AML) fusions and mutations to improve clinical outcomes for patients. The parent award
builds on a CRISPR-based single molecule long-read sequencing assay (CSRL) to detect clinically relevant
mutated genes in AML by including additional prognostic and predictive markers. The improved assay will be
validated using known cell line mixes and patient samples. Aim 1 of the parent R21 will also create bioinformatics
workflows to enable same day data analysis using the open-source Biodepot-workflow-builder (Bwb) platform.
The Bwb platform will be extended to detect fusion and DNA variants. Aim 2 of the parent R21 will compare our
assay performance to established clinical grade tests on archival specimens, and evaluate clinical impact of
phasing data and fusion breakpoints on prognosis and treatment response. Aim 3 of the parent R21 will
demonstrate the clinical impact of our molecular profiling assay and bioinformatics platform through a pilot study
on samples from the clinic, ease of same day testing and reporting, and study of the impacts that same day
results can potentially have on patient treatment. Our CSRL assay, combined with new bioinformatics
approaches, will establish potential use in the clinic for an ultrarapid same-day informative molecular profiling
assay for AML to guide oncologists for immediate therapy implementations.
In this supplement, we will employ software engineering best practices to extend the Bwb platform to enable
execution of modules on different platforms that are specified at runtime. Bioinformatics workflows will be able
to simultaneously utilize different resources and leverage the enhanced security and reduced data transfer of
local devices while benefiting from the scalability of the cloud. This hybrid cloud computing approach would be
beneficial for the parent R21 as steps involving large files (basecalling and alignment) could be done locally on
a GPU enabled laptop, server, or dedicated device resulting in the transfer of smaller files to the cloud for
computationally intensive deep-learning based variant calling. Bwb currently has specialized workflows with
modules that run simultaneously on the cloud and locally. The supplement will allow users to specify the
execution platform for modules at runtime without the need to re-write the workflow. We will support a full-time
research software engineer and add a new collaborator with expertise in software engineering and cloud
computing. This hybrid cloud implementation will be applied and benchmarked using data generated in the
parent award and the test suite will be saved and distributed as part of the workflow. We will also provide a single
sign-on service to simplify the additional authentication needed for execution on multiple platforms. All software
developed will be public and open-source. These improvements will provide a robust open-source platform for
other multi-omics and imaging data workflows to leverage emerging hybrid cloud and edge computing
technologies.

Public health relevance
PROJECT NARRATIVE Best practices of software engineering principles will be employed to develop easy-to-use open-source software platforms to enable hybrid cloud analysis of bioinformatics data. The resulting robust and portable software has the potential to improve diagnostics and treatments by accelerating data processing, reducing cloud computing costs, and reducing the need to transfer patient sensitive sequence data.